Genomics Shared Resource (GSR)

GENOMICS SHARED RESOURCE (GSR)
ABSTRACT
The objective of the UCLA Jonsson Comprehensive Cancer Center (JCCC) Genomics Shared Resource (GSR)
is to enable and enhance members’ cancer research. This objective is being achieved through mechanisms that
group into: (1) Developing state-of-the-art next generation sequencing (NGS) technologies, services, and
solutions; (2) Fostering interdisciplinary collaborations and interactions; (3) Providing ready access to
technologies, services, and scientific consultations; and (4) Furthering productivity to maximize the scientific
impact of JCCC investigator research. GSR management within the JCCC is led by Associate Director of Shared
Resources Zoran Galic, PhD (TII), and a four-member GSR Faculty Advisory Committee (FAC), in collaboration
with Elaine Reed, PhD, Endowed Chair in Diagnostic Medicine, Professor of Pathology and Laboratory Medicine
and Director of the UCLA Immunogenetics Center. Under the leadership of GSR Director Xinmin Li, PhD
(ERGR), and Co-Director Hyun-Ju Lim, PhD, GSR has a highly trained team of 18 genomics and bioinformatics
staff, including nine PhD scientists. Housed within GSR are cutting-edge genomics technologies including a
Novaseq X plus sequencer, DNBseq T7 sequencer, GridION long sequencer, 10X Chromium IX and BD
Rhapsody single cell systems, a 10X Visium CytAssist, a 10X Xenium Analyzer, a GeoMx Digital Spatial Profiler,
a CosMx Spatial Molecular Imager, a 10X Genomics Chromium Connect, a Beckman Coulter Biomek i7, and a
Life Tech EVOS M7000 microscope. Empowered by these recent technological innovations and capabilities,
GSR provides >70 different genomics menu services, including bulk, single cell, and spatial multi-omics analyses
and data management that are timely and cost-effective. GSR services are prioritized for JCCC members. GSR
also offers alternative platforms for major technologies tailored to meet specific scientific requirements. This
variety of capabilities enable JCCC investigators to tackle a wide range of complex and multifaceted questions.
From 2019 – 2023, GSR served 111 different JCCC investigators from all six JCCC Research Programs. In
addition to providing services, GSR supports JCCC investigator labs with education, consultation, expertise, and
innovation. Since 2019, GSR has offered 31 lectures, seminars, and workshops with approximate attendance
by JCCC members ~650 times at these events. Li has written >130 grant support letters, with approximately
18% funded, and has provided expert revisions for numerous manuscripts and grant applications. This multidimensional
support resulted in impressive scientific and financial impact, with GSR support contributing to 226
publications with 55% appearing in high-impact (IF >10) journals, newly awarded extramural grants totaling
$193M, and 21 patent applications from 2019 – 2023. GSR has consistently shown and will continuously make
impactful contributions to JCCC cancer research, which prioritizes the needs of its Los Angeles County
catchment area residents.